Wearable Shear Wave Tensiometry for Tracking Tendon Load during Dynamic Movement

Project Summary The long-term goal of this project is to develop a wireless, wearable system to estimate the tension in tendons of the legs during dynamic movements. Tendon tension provides an estimate of muscle force, which is important information for understanding biomechanical behavior in all types of movement, though it has previously been difficult to measure. Recent advances have shown that skin-mounted accelerometers can track the propagation of shear waves along a tendon, after the waves are induced by a light mechanical tap on the tendon. The speed of wave propagation depends on the tension in the tendon, so measuring wave speed provides a measurement of tendon tension. The proposed project will build and test a wearable system to make these tendon tension measurements during free movement. These measurements promise to enable new methods of injury assessment, rehabilitation, athletic training, and treatment of musculoskeletal disorders. This research will investigate the ability of a mobile system to make measurements that match the quality of laboratory systems, and the ability of tendon tension measurements to provide insight into biomechanics during movement in everyday environments. The Specific Aims of this project are to: 1. To design, build, and validate a wearable system for measuring tendon tension through measurements of shear wave propagation speed in tendon. 2. To investigate the utility of wearable tendon tension measurements for assessing biomechanical function during real-world activities.

Public health relevance
Project Narrative (Public Health Relevance) Knowledge of muscle forces is critical for understanding coordination, energy consumption, and injury; for quantifying responses to interventions such as surgery or rehabilitation; for improving performance in demanding biomechanical tasks; and for designing biomechanical devices such as rehabilitation equipment and robotic exoskeletons. Unfortunately, most current techniques for estimating muscle force are indirect and reliant on complex modeling assumptions. The direct measurement of in vivo muscle-tendon forces has remained one of the great unsolved biomechanics problems. We recently discovered that the propagation speed of shear waves in tendon can be used to infer tendon tension, and invented a simple skin-mounted probe to measure this wave speed noninvasively. The proposed research program aims to develop this laboratory-based tendon tensiometry technology into a wearable, wireless commercial system that can be used anywhere. The advent of a field-based tendon tensiometry system has the potential to catalyze many further scientific and technological advancements, such as estimating in-activity muscle-tendon force and energy consumption, resolving muscle redundancy in biomechanical models, assessing neuromusculoskeletal disorders, providing biofeedback for rehabilitation, and controlling human-collaborative robots.